SOUTHWEST ONCOLOGY GROUP

To participate in the multidisciplinary approach to the design and conduct of clinical trials in malignant diseases. These diseases include adult solid tumors, lymphoma, multiple myeloma, leukemia, and other neoplasms to be studies by the Southwest Oncology Group. These studies will be classified as phase I for the evaluation of toxicity, tolerated dosage and therapeutic range of new combinations of agents; phase II to determine the frequency, extent and duration of remission with new agents; and phase III to establish the relative efficacy of various therapeutic regimens in neoplastic diseases. To investigate some of the biochemical and biological aspects of the neoplasms under study as they derive from patient material available for the cooperative studies. To actively participate in and contribute to the overall Group effort. This will include scientific input, support in protocol design, chairmanship of studies and requested administrative tasks.